Development of Cancer Care Shortage Areas Using Geospatial Analysis and Spatial Network Optimization Techniques

PROJECT SUMMARY
The ability to identify cancer care shortage areas (CCSAs) is crucial to inform actionable policies that improve
health outcomes (e.g., live longer) and reduce health disparities (e.g., better served versus underserved
communities). With the increasing demands from 18.1 million cancer survivors1 and fewer healthcare providers
(e.g., 200 or more rural hospital closures2 and shortages of 86,000 physicians3) in the U.S., contemporary
knowledge is lacking regarding which areas and populations are most affected by cancer care shortages.
Historically, health care shortage areas are identified using the U.S. Department of Health and Human
Services (DHHS) designation of health professional shortage areas (HPSAs) and medically underserved areas
or populations (MUAs/Ps) to prioritize resources to high-need communities.4,5 Both influential systems are built
on rational service areas (RSAs) and apply population-to-provider ratio and poverty as two common indicators
to identify areas lacking access to primary, dental, and mental health care services.4,5 However, the definition
of RSAs is largely descriptive and lacks a uniform approach, and identifying RSAs as shortage areas relies on
the local knowledge of health care officials.5,6 Although the DHHS uses census units (e.g., counties) to define
RSAs5, they are often criticized for not accurately representing health care markets (e.g., patient border
crossing)6,7 or specific cancer care markets which differ from general health care markets found in our prior
work.7 These issues lead to inaccurate measurement of the population-to-provider ratio which overlooks the
interaction between populations and providers.8 Healthy People 20309 demonstrated a need to consider
additional nonspatial (or social) factors beyond poverty which include demographic, socioeconomic, and
cancer risk behavioral factors that contribute to the observed disparities in access to care.10-13 Given the
limitations of existing methods to measure and address cancer disparities and the emergence of advanced
geospatial, network science, and machine learning methods, the goal of this project is to develop CCSAs and
disseminate data and tools to help researchers, professionals, policymakers better identify areas and
populations with the greatest need of cancer care in the U.S. The new approach will overcome the
weaknesses of prior methods by capturing cancer care utilization patterns of underserved communities and
improving the accuracy of measuring access to cancer care to more comprehensively reflect their needs.
Through this study, our team will produce methods for defining CCSAs that are novel, specific to cancer care,
and more comprehensively incorporate spatial and nonspatial indicators of access. Further, we will develop an
interactive, web-based tool to disseminate CCSAs which can be used by policymakers, healthcare
administrators, and scientists within cancer research and control communities to promote care expansions,
allocate resources, and enhance community engagement and outreach efforts in shortage areas. The methods
developed could also be applied to improve the designation of general health care shortages.

Public health relevance
PROJECT NARRATIVE Inadequate and unequal access to cancer care may continue to exacerbate cancer health disparities given increasing demands from a growing population of cancer survivors, rural hospital closures, and significant physician shortages. Existing studies have lacked the definition of cancer-specific rational service areas (RSAs) capturing utilization-based cancer care markets, which are distinct from general health care markets, and have failed to integrate both spatial (e.g., distribution of oncologists and primary care physicians) and nonspatial (e.g., demographic, socioeconomic, and health risk behaviors) indicators of access. This study will leverage advanced GIS, spatial network optimization, and machine learning methods to define U.S. cancer care shortage areas (CCSAs) which will be widely disseminated through our newly developed interactive, web- based mapping tools to inform better cancer control efforts and decision making.